Delaware Clinical and Translational Research ACCEL Program (Admin Core)

ABSTRACT- ADMINISTRATIVE CORE
The ACCEL CTR Program has successfully met the expectations of this award mechanism by expanding the capacity for clinical and translational research in Delaware and enhancing our investigators’ ability to successfully compete for extramural funding in this arena. The success of ACCEL is anchored in the complementary strengths of the partnership network built over the past nine years. Our current network consists of the University of Delaware (lead institution), Christiana Care Health System, Nemours Children’s Health and Delaware State University. To date, ACCEL has established an exceedingly strong network and infrastructure for clinical and translational research within Delaware; and, we are now poised and ready to continue our growth trajectory by building a deeper focus on improving the health of all Delawareans into our clinical and translational research infrastructure. The planned components of the ACCEL Program include the Administrative Core and five other required Cores, including: the Professional Development Core; the Biostatistics, Epidemiology, & Research Design Core; the Community Engagement & Outreach Core; the Pilot Projects Program, and the Tracking and Evaluation Core. The overall goal of the Administrative Core is to improve the efficiency, productivity and impact of the five other Cores so that we are able to successfully meet our common mission of building clinical and translational research infrastructure that will be sustainable and ultimately improve the health of Delawareans. We believe that we have a very effective administrative structure that does not require substantial change. But, in this renewal application, we propose an exciting new addition to the Administrative Core—an Implementation Scientist, who will work closely with all Core leaders to spearhead initiatives focused on how our network is improving healthcare for all Delawareans, with a focus on cultural respect. The Specific Aims of the Administrative Core are to continue to: (1) Provide a flexible and efficient administrative and governance structure that enhances the DE-CTR ACCEL Program’s ability to grow and sustain clinical and translational research programs that address the most important health care needs of Delawareans and all Americans; (2) Manage the financial and business operations of the DE-CTR ACCEL Program to ensure operational efficiency, sound fiscal health of the organization and compliance with all federal, state and local regulations; (3) Enhance and promote data-informed decision-making, communication and collaboration across all ACCEL components, participating institutions and other IDeA programs; and (4) Facilitate the implementation of strategic, high-value initiatives that will enhance the ACCEL Program’s ability to develop healthcare solutions for all and improve infrastructure for clinical and translational research within the state of Delaware.

Public health relevance
Project Narrative While Delaware has high quality healthcare compared to other states, it still lags behind other states in a number of areas, including drug-related deaths, obesity, high preventable hospitalization rates, multiple chronic conditions and cancer. As such, the overarching goal for the continuation of the ACCEL CTR Program is to create a unified Delaware Clinical and Translational Research Community (inclusive of investigators and community members) that breaks down existing barriers, capitalizes on the unique strengths of its partners to establish infrastructure and accelerates the creation of solutions that improve the health of all Delawareans and all Americans